Statistical Methods for Evaluating Markers for Treatment Selection

Project Summary Biomarkers that predict the effects of therapeutic or preventative treatments hold great promise for im- proving health outcomes and decreasing medical costs. For example, if a treatment is thought likely to beneﬁt only a subset of subjects, a biomarker that identiﬁes these subjects can be used to recommend the treatment to them, and allow others to pursue alternatives. Potential treatment selection biomarkers, also called predictive or prescriptive biomarkers, are being produced in abundance due to technological advancements and a heightened interest in “personalized medicine”, and yet a comprehensive statistical framework for study design and analysis of biomarker performance is lacking. We propose to build on a successful research program to develop novel statistical methods for marker identiﬁcation and evaluation, with the ultimate goal of advancing such a framework. Aim 1 develops novel statistical analysis methods for discovering and evaluating markers for guiding treatment. The ideal setting for marker evaluation is a randomized and controlled trial. For this setting we will develop methods that address challenges not accommodated by existing methodology. For early-phase marker studies, which are typically not random- ized trials, methods for evaluating a biomarker's potential performance do not yet exist and our research will ﬁll this gap. Methods will also be developed that incorporate medical cost data into the evaluation of a biomarker. Aim 2 will develop novel study designs for discovering and evaluating markers for guiding treatment. A basic ﬁrst step in study design is identifying what is the desired performance of the biomarker, and we will develop techniques for this. Study designs will then be developed to assess whether a marker achieves this standard. Early-phase studies? either cohort studies or single arm trials? will be sized to evaluate a marker's potential performance. Novel randomized trial designs will be developed to deﬁnitively assess marker performance and will require smaller sample sizes than existing designs. A sequence of studies will be put forth for developing a biomarker, from early-phase studies of potential performance to late-phase studies of actual performance. The research will be conducted by an inter-disciplinary team of investigators with extensive expertise in biomarker evaluation, clinical trial design and analysis, health economics, and clinical research. Collaborations with cooperative groups such as the Early Detection Re- search Network, focused on biomarker discovery and evaluation, and SWOG, focused on clinical trials of cancer prevention and therapeutic strategies, will ensure that the research has immediate application and impact. Studies to which the methods will be applied include one that aims to identify women at high risk for epithelial ovarian cancer who can be recommended prophylactic removal of the fallopian tubes at the time of hysterectomy; and another that seeks to identify women with estrogen-receptor-positive breast cancer who are unlikely to beneﬁt from adjuvant chemotherapy.

Public health relevance
Project Narrative Markers that predict the likelihood an individual will beneﬁt from a medical intervention for disease pre- vention or treatment hold great potential public health value. This proposal will develop standards for the statistical design and analysis of studies discovering and evaluating candidate markers. These standards will help distinguish the good markers from the bad, optimize how the markers are used to make treatment recommendations, and ensure that research studies are designed so that the markers can be properly evaluated.